Center for Population Health and Aging

Abstract/Summary: We propose an administrative supplement to enhance the existing longitudinal
Dunedin Study with, per NOSI-AG-22-022, “new exposure measures and mechanisms linking exposures
to AD/ADRD outcomes.” The NOSI calls for new research infrastructure that “addresses the role of
diverse physical, chemical, social, psychological, and economic exposures across multiple levels and
across the life course in the etiology and social disparities” of AD/ADRD. The Dunedin Study, now in its
5th decade, has led the field in tracking social, psychological, and economic exposures since our cohort’s
birth in 1972, using multidisciplinary methods spanning sociology, psychology, medicine, dentistry,
sensory science, and economics. Here we propose to collect chemical and physical exposure data at
Dunedin Phase 52. Doing so will make the Study one of the world’s first truly “exposomic” investigations
of life-course brain aging and AD/ADRD risk. We propose to measure toxic metals, home environmental
quality, and neighborhood environmental quality.

Public health relevance
5.5.2. SPECIFIC AIMS PROJECT NARRATIVE We propose an administrative supplement to enhance the longitudinal Dunedin Study now in its 5th decade, which has led the field in tracking birth in 1972.Here we propose to collect new exposure measures and mechanisms linking exposures to AD/ADRD outcomes: new physical and chemical exposure measures of toxic metals, home environmental quality, and neighborhood environmental quality. Doing so will life-course brain aging and AD/ADRD risk.